Advancing, Expanding, and Streamlining University of New Mexico Health Sciences Center Animal Resource Facility Rodent Housing Capabilities

PROJECT SUMMARY/ABSTRACT
The aim of this R24 proposal entitled “Advancing, Expanding, and Streamlining University of New Mexico
Health Science Center Animal Resource Facility Rodent Housing Capabilities” is a request for $350,000 to: 1)
Support purchase of 10 ventilated rodent racks with cages/accessories and associated mechanical and
electrical construction to provide connection of these units to building exhaust and electrical in two rodent
housing rooms; 2) Purchase two Class II Type A2 animal handling biosafety cabinets for use in rodent
research suites. The total space affected by this project is 601 sq ft. This project builds upon improvements
from renovation projects completed in 2002, 2008, 2013, 2021, 2022, and 2023, including several expansions
and improvement in ABSL-2 housing capabilities. These past renovations upgraded mechanical (HVAC w/
DDC controls and environmental alarms), floors, finishes, roofing, replacing the tunnel and rack washers, three
cage and equipment autoclaves, and renovated all mouse housing rooms to accommodate individually
ventilated rodent racks in all mouse housing areas. This proposed project will add ventilated mouse racks to
expand and consolidate animal biosafety level-2 housing in G95, a mouse housing room adjacent to the
mouse breeding barrier, which supports 20 investigators. The racks that will be purchased will be compatible
with existing caging with the large cages (180 in2/cage – 36 cages/rack) that can be used in any rack in the
breeding barrier by interchanging with small cages (75 in2/cage) (2 small cages fit in the slot for 1 large cage).
We propose the large cages to allow us to support trio breeding with adequate space per breeding female, as
recommended under the 8th edition NIH guide. Second, we propose to renovate and add ventilated racks (5
racks/room) in G82B, a mouse room in the specific pathogen free (SPF) research suite. These proposed
ventilated racks are single sided units with capacity of 72 cages (75 in2 /cage) per unit. This rack format will
allow us to increase space in the breeding barrier by 25% (288 to 360 cages). This SPF mouse research suite
currently supports 18 PI laboratories. These rooms are currently near capacity and 3 new faculty with mouse
research programs have been hired and their mice breeding will be operational in ARF by January 2024. Third,
we will purchase animal handling equipment for each respective animal room (G95 and G82B) as Class II
Type A2 animal handling biosafety cabinets.

Public health relevance
PROJECT NARRATIVE “Advancing, Expanding, and Streamlining University of New Mexico Health Science Center Animal Resource Facility Rodent Housing Capabilities” requests funds to support purchase of ten ventilated mouse racks with cages/accessories and two Class II Type A2 animal handling biosafety cabinets as flexible clean working stations. The University of New Mexico (UNM) Health Sciences Center (HSC) Animal Resource Facility (ARF) supports approximately 77 biomedical and behavioral research investigator laboratories (44 PI laboratories affected by this project). This project, when completed, will allow us to increase needed cage capacity, improve room and cage air quality, and improve research procedural space as a means to sustain ongoing strategic goals: expand a productive partnership between the NIH and UNM HSC; develop new synergies among research programs to enhance Signature Programs (Brain and Behavioral Illnesses, Cancer, Cardiovascular and Metabolic Disease, Child Health Research, Environmental Health Sciences, and Infectious Diseases and Immunity); and modernize the animal core in compliance with required standards and maintenance of AAALAC accreditation.